T32 Urologic Oncology Research Training Grant

PROJECT SUMMARY/ABSTRACT
Since its inception in 1999, the primary objective of the T32 Urologic Oncology Research Training
Program at Memorial Sloan Kettering Cancer Center (MSK) has been to train select urologists for
productive careers as surgeon-scientists in translational research in urologic oncology. Dedicated
research training in urologic oncology is essential to the mission of the National Cancer Institute (NCI) to
reduce morbidity and mortality from genitourinary cancers, which cause about 10% of all cancer-related
deaths in the United States and which are expected to rise steadily in incidence as the population ages.
To achieve our primary objective, we seek to continue our interactive, multidisciplinary research training
strategy that integrates the following: (1) a multidisciplinary faculty of basic, clinical, and translational
researchers spanning the disciplines of surgery, medicine, cancer biology and therapeutics, molecular
pathology and genetics, immunotherapy, molecular radiology, biostatistics and epidemiology,
computational oncology, biomarkers, and health services and health disparities research; (2) an intensive
mentored research practicum tailored to the T32 trainee’s research interests and goals; (3) a core
curriculum of required didactic and discussion-based courses to enhance the quality of the hands-on
research training; (4) structured career development workshops in grant writing and career development
awards; and (5) elective activities that will allow T32 trainees to further immerse themselves in the world
of cancer research and to network with peers and established leaders. We continue to enhance the
program by revising and adding new elements to these 5 components of our training strategy, as well
as maintaining an outstanding cadre of program faculty mentors who are selected based on research
relevance and productivity, qualifying funding, and quality of mentoring. Each year, 2 highly committed
postdoctoral trainees from the Urologic Oncology Fellowship Program at MSK are selected for the T32
Urologic Oncology Research Training Program. They must have an MD, must have completed residency
training in urology, and must be board-eligible urologists. These 2 trainees are supported by this T32
training grant during 2 years dedicated to urologic oncology research training, with appointment to the 2nd
year contingent on suitable progress. At the completion of their training, graduates of theT32 Urologic
Oncology Research Training Program are expected to be attractive candidates for junior faculty
appointments at research-focused academic organizations. In the past 15 years, 87% of T32 trainee
graduates have matriculated to faculty positions at academic institutions and are engaged in laboratory
and/or clinical research aimed at understanding and overcoming genitourinary cancers.

Public health relevance
PROJECT NARRATIVE The T32 Urologic Oncology Research Training Program at Memorial Sloan Kettering Cancer Center (MSK) trains qualified urologists for academic careers as surgeon-scientists focused on eliminating suffering and death from genitourinary cancers, which comprise 21% of all non-skin cancers and cause 10% of all cancer deaths in the United States.